Mali ICEMR- Data Management and Biostatistics Core

CORE B – SUMMARY
Wide deployment of malaria control tools in the past decade has significantly contributed to substantial
reduction of the incidence and deaths related to the disease in Sub-Sahara Africa. Yet, the region continues to
carry a disproportionately high share of the global malaria burden of malaria deaths. Moreover, incidence
remains high but stable in some settings while rebounding in others after a long period of decrease associated
with intensive deployment of malaria control tools. The Overall goal of this ICEMR is to understand the variable
effectiveness of current malaria control interventions in different ecological settings of West Africa through
research to understand interactions between the parasite (response to drug treatment, genotypes, gametocyte
survival), human (immune response and host genetics) and the vector (ecology, behaviors, and response to
insecticides) and regulating influences of the local environment and human behavior. The goal of the Data
Management and Biostatistics (DMB) Core is to provide data management and biostatistical support to the
ICEMR investigators of Mali in order to produce reliable and high quality research data and data analysis. The
specific aims of DMB are: 1]To set up a data management system office meeting all standards of
confidentiality, reporting, data quality, and data security to support, in collaboration with the ICEMR
investigators, 2] To support ICEMR investigators in study planning, study conduct and data management
activities including: project management, data collection, data entry, study quality assurance, data storage, and
retrieval, and updating standard operating procedures, and in database management and processes; 3]
Support ICEMR investigators in protocol designing and development, in monitoring of studies, and in both
interim and final data analyses; 4] To provide required training in clinical research and data analysis for
investigators and technicians to meet all standards. The Core B will be based at the NIH-University of Bamako
Center of Excellence in Research, Mali.